NEW CHEMICAL APPROACHES TO ADP-RIBOSYL TRANSFER

ADP-ribosyl transferases are an important class of regulatory enzymes. This project proposes the design and affinity labels specific for the NAD substrate binding site of ADP-ribosyl transferases. The information sought is the identification of catalytically essential amino acid residues and elucidation of active site structure. Identification of essential amino acid residues and elucidation of active site structure. Identification of essential amino acid residues will advance the understanding of the mechanism of these unique catalysts. This information will support the development of genetically engineered vaccines against pertussis and related diseases where a microbial ADP- ribosyl transferase functions as an exotoxin component. Affinity and photoaffinity labels will be applied to the study of the mammalian NAD glycohydrolase as an example of a hydrolytic transferase and to the catalytically active . A subunits of cholera toxin, pertussis toxin, and diphtheria toxin. These toxins are medically important and are significant as representatives of the class of mono (ADP-ribosyl) transferases which has been implicated as a new cell regulatory mechanism. Neither affinity labels nor photoaffinity labels specific for the NAD substrate binding site and generally applicable to enzymes in the class are currently available. All such enzymes exhibit significant NAD glycohydrolase activity. Successful labels must therefore be noncleavable NAD analogues. The first approach to the production of affinity labels and photoaffinity labels is therefore made possible by our development of the non-cleavable analogues. The first approach to the production of affinity labels and photoaffinity labels is therefore made possible by our development of the non-cleavable analogue carba-NAD. Here a cyclopentane ring replaces the beta-D-ribotide of the nicotinamide riboside moiety of NAD. Carba-NAD has been demonstrated to be resistant to ADP-ribosyl transfer and to be an effective competitive inhibitor of NAD glycohydrolase and several mono (ADP-ribosyl) transferases. A family of related affinity labels and photoaffinity labels will be produced by modification of carba-NAD and applied to the study of the aforementioned enzymes. A second strategy for inhibitor design will utilize amino sugars as "transition-state analogues" to mimic the oxocarbonium ion intermediate proposed for the mammaliam NAD glycohydrolase. A synthesis of 1,4- dideoxy-4-amino-D-ribofuranose is available and incorporation of this amino sugar into an ADP-ribose analogue will readily be accomplished. The "transition-state analogue" will be tested as an inhibitor of NAD- glycohydrolase and the microbial toxins.